ORAL-MAXILLOFACIAL SURGERY AND MOLECULAR BIOLOGY

Project has not been decided on as of yet, however, the following are examples of research currently being worked on or planned. 1. Tissue engineered autogenous graft material for use in cleft palate reconstruction. 2. Immunohistochemical characterization of the extracellular matrix of the developing tooth bud in the primate. 3. Interaction of the Epstein-Barr virus with oral tobacco in the formation of oral cancer.